Health systems innovations for supporting transitions of care for incarcerated people living with substance use disorders

ABSTRACT
Adults incarcerated in the United States are disproportionately affected by substance use disorders and
chronic physical and mental conditions, and have a high risk of death after release from prison. Medicaid
coverage for formerly incarcerated adults increases access to care, but is likely insufficient by itself to
substantially improve outcomes without attending to the numerous social and structural barriers that make
accessing care difficult. Prior research demonstrates that formerly incarcerated adults under-utilize routine,
outpatient health care during the transition from prison to community living, suggesting a dire need for
systems-level interventions aimed at improving engagement in primary care. In a prior study funded by NIDA,
our team developed a hybrid, in-person and telephone-based nurse case management intervention that
bridges the pre-release and post-release period and conducted a single-arm pilot trial in two Wisconsin state
prisons. We found that the likelihood of an outpatient care visit shortly after release among those who received
the intervention was nearly double the baseline rate, while being highly acceptable to prison staff. In the
proposed Renewal Application, we will conduct a two-arm, randomized clinical trial among incarcerated adults
with a history of substance use, that compares previously piloted transitional case management intervention,
called CJC-TraC, to an enhanced usual care condition consisting of routine multi-disciplinary release planning
and provision of a free cellphone at the time of release. The primary and secondary trial outcomes are
attending an outpatient visit within 60-days of release for any cause and for a substance use disorder
respectively. In the proposed study’s second aim, we will leverage novel linked administrative data and
observational research methods to investigate care transition research questions that are policy-relevant but
cannot be pursued in a randomized trial of incarcerated adults: estimating the relative effectiveness of the trial
arms to usual care; assessing the generalizability of trial results to the target population; and measuring the
association between post-release outpatient care use and longer-run health and criminogenic outcomes.
Improving access to post-incarceration health care is a major federal policy priority. In 2023, the Centers for
Medicare and Medicaid services published Section 1115 Medicaid demonstration waiver guidelines for states
to provide Medicaid coverage and care transition services to incarcerated individuals during the pre-release
period and post-incarceration. The waiver program represents an unprecedented opportunity to bring care
transition services for incarcerated individuals to scale; however, there is limited information identifying what
constitutes an effective and scalable care transition program. By testing the effect of a prison system-based
intervention able to be replicated and scaled up across multiple settings, findings from this study can have a
significant impact on the health of a high-priority, medically underserved population.

Public health relevance
PROJECT NARRATIVE / PUBLIC HEALTH RELEVANCE People incarcerated in the United States are disproportionately affected by substance use disorders as well as chronic physical and mental health conditions, yet are known to under-utilize health services during the transition from prisons to communities. Reducing health disparities in this population requires evidence-based strategies to connect recently-incarcerated people to community-based care. This project will conduct a 2-arm randomized clinical trial to test the effectiveness of a protocolized transitional nurse case management intervention initiated prior to release and continuing for 3 months after release with phone-based support.